All of Us New England Remote Enrollment and Engagement, Nutrition for Precision Health Support

The All of Us Research Program is a landmark longitudinal cohort study that aims to enroll 1 million or more participants reflecting all populations of the United States and create a unique biomedical data resource that can advance precision medicine and improve health. Since 2016, the All of Us New England Consortium (AoUNE) has contributed to the success of the national program by enrolling individuals in Eastern Massachusetts through a collaboration of Mass General Brigham (MGB), New England's largest regional health system, and Boston Medical Center (BMC). In the process, we have designed and implemented robust procedures for staff onboarding and training, site activation, recruitment, participant enrollment and retention, data transfer and biospecimen collection. To date, we have enrolled more than 35,000 core participants and retained our participant partners (PPs) through both passive and active retention activities. In addition, we have successfully referred AoU participants who have opted into the Nutrition for Precision Health (NPH) study, and the New England NPH consortium leads the nation in recruitment for this Partnered Research Study. We have also contributed to the national All of Us Program through participation and leadership roles in multiple national committees and task forces responsible for the program’s governance, scientific roadmap, and data collection operations. We now propose to refocus our efforts on enrollment, EHR data transfer, and active and passive retention of the existing All of Us New England cohort.

Public health relevance
The goal of this project is to engage, enroll and retain a large cohort of health system patients who have contributed data and biospecimens to the All of Us Research Program to advance the future of precision medicine. It is relevant to public health because it supports a longitudinal national research resource and partnered research studies focused on understanding the biological, environmental, and social drivers of health and disease.